Noninvasive Measures in Wheezy Infants and Toddlers

DESCRIPTION (provided by applicant): Recurrent wheezing is common in early childhood, affecting over 20% of children. Noninvasive methods to diagnosis airflow obstruction and airway inflammation are lacking in infants and toddlers, making it difficult for clinicians to separate transient wheezing of early childhood from early persistent asthma. If such methods were available they would assist medical care providers with the early diagnosis of asthma, provide a rationale basis for the initiation of daily inhaled corticosteroids, and perhaps reduce early decline in lung function through timely therapeutic intervention. The overall goal of this research is to characterize longitudinal noninvasive measures of airway inflammation and airflow obstruction in a cohort of infants with a history of recurrent wheezing/and age- matched healthy infants. Dr. Debley will assess the associations of longitudinal measurements of exhaled nitric oxide, cysteinyl leukotrienes in exhaled breath condensate, and the thoracic index (an anthropometric measure of pulmonary hyperinflation), with symptoms and infant pulmonary function measures using the raised-volume rapid thoracic compression technique. He will also compare longitudinal values of these noninvasive measures between infants with recurrent wheezing and infants without respiratory symptoms. Dr. Debley's career goal is to become a leader within the subspecialty of pediatric pulmonology in the study of children with recurrent wheezing, with particular expertise in the non-invasive assessment of airflow obstruction and airway inflammation in young children. He proposes a rigorous 5 year career development plan supervised by four outstanding and experienced mentors, which will provide him with enhanced skills and knowledge in several new areas relevant to his research plan and career goals, including: the performance and interpretation of infant lung function using the raised-volume thoracic compression technique, the collection of exhaled breath condensate and analysis of its constituents, the application of statistical methods used to analyze longitudinal data, a comprehensive understanding of nitric oxide biology including the analysis of exhaled nitric oxide in young children, and a detailed understanding of inflammatory mediators in asthma.